The endocytic requirements for mechanosensitive Notch activation in vivo

Abstract.
Notch is a conserved transmembrane receptor that has important functions in animal
development and its dysregulation causes diverse human disorders and cancers. An
understanding of the initiation and regulation of Notch signal transduction is therefore important
to human health. A key event in Notch activation is the exertion of mechanical force on the
receptor ectodomain which triggers a proteolytic cleavage of Notch that ultimately precipitates the
intracellular domain, a transcriptional activator, translocating to the nucleus. This activating force
is provided by ligand endocytosis into the signal sending cell, but remarkably only a select route
of endocytosis involving the endocytic adapter protein Epsin can generate this force. Furthermore,
in the Drosophila wing, only a small proportion of the Notch ligand Delta enters the cell via this
route. Here we propose to resolve the critical aspects of Epsin-mediated ligand endocytosis that
allows the exertion of activating force across a ligand/Notch bridge. We will extend our existing in
vivo tools and genetic protocols to study ligand/receptor interactions to incisively control signaling
from mutant cells, monitor transendocytosis of the ligand/receptor bridge, and conduct
biochemical assays. First, we will confirm that the primary role of Epsin is to link Notch ligands to
the Clathrin route of endocytosis, and identify the endocytic route responsible for the
internalization of Delta excluded from the Clathrin route. Second, we will probe the force
generating capacity of Epsin and non-Epsin routes of ligand-endocytosis. Finally, we will
investigate the endocytic behavior of the Drosophila ligand Serrate that is largely endocytosed via
the Epsin route and is potentially itself mechanosensitive. If successful, the proposed experiments
will identify additional steps in Notch activation, new possibilities that could regulate the sending
of signals to Notch, and general principles relevant to multiple juxtacrine signaling molecules
subject to Clathrin-mediated endocytosis and proteolysis.

Public health relevance
Narrative The Notch receptor governs an important means of intercellular communication, used pervasively in all multi- cellular animals in development and physiology, yet the precise mechanosensitive mechanism by which Notch is activated is not fully understood. The proposed research investigating how force is generated to activate Notch is relevant to public health because dysregulation of Notch activation is a major source of human disease, associated with a wide range of cancers, developmental and immune disorders, neurological impairment, and reduced healthspan. Thus, the research is relevant to NIH’s mission to reduce the burden to society arising from genetic and environmental disorders of fundamental aspects of human development and physiology.